Metabolic and Transcriptional Reprogramming of Cardiac Maturation

Project Summary
Recent advances in stem cell science have led to accelerated progress in cardiac regeneration. Our group
successfully achieved large-scale re-muscularization of the infarcted hearts of macaque monkeys by
transplanting human cardiomyocytes derived from pluripotent stem cells (hPSC-CMs). These cardiomyocytes
restored ejection from ~40% to ~62%, the largest restoration of cardiac function of which we are aware. This
therapy is complicated by the appearance of transient ventricular arrhythmias, which last for several weeks
before disappearing. Our electrophysiological studies indicate that the arrhythmias result from pacemaking
activity, which in turn results from the immaturity of the hPSC-CMs at the time of transplantation. The main
goal of this proposal is to enhance the maturation of hPSC-CM to make them non-arrhythmogenic, using
metabolic and transcriptional reprogramming. In Aim 1 we build on our observations that modulating
metabolism has wide-ranging effects on maturation, including reducing automaticity, and increasing
physiological hypertrophy, force production, and more adult-like calcium cycling. The most powerful metabolic
interventions, substrate switching, metabolic hormones, and energy sensing, will be systematically optimized to
enhance electrical maturity in vitro. Once optimized, we will explore the underlying mechanisms, and then test
whether this maturation reduces arrhythmias by transplanting them into porcine hearts. Aim 2 takes advantage
of a recently generated resource, where we performed RNA-seq on a timed series of human myocardial grafts
in the rat heart as they matured to adult levels in vivo. By comparing these data to immature cardiomyocytes,
we identified a set of transcriptional regulators that are candidate drivers of maturation. We will perform
CRISPR-based gain-of-function studies to activate these factors in vitro. Using gene expression and
electrophysiology analyses, we will then identify optimal combinations to enhance maturation. If successful,
these studies will solve the greatest barrier to stem cell-based heart regeneration and bring us much closer to
clinical trials.

Public health relevance
Project Narrative We have developed techniques to regenerate the injured heart using stem cells that restore pump function but make the heart electrically unstable for several weeks. This proposal aims to solve this electrical instability by reprogramming stem cell metabolism and gene regulation. If successful, these studies can lead to a transformative regenerative therapy that could help millions of patients suffering from heart disease.